Imaging Core

SUMMARY FOR CORE B
The Imaging Core will provide comprehensive support for the in vivo imaging studies within the PPG projects.
The core will be operated at the BioMedical Engineering and Imaging Institute (BMEII) at Mount Sinai under
the direction of Core Director Dr. Philip Robson (Mount Sinai). Other members of this core will include
dedicated image analysts, data managers, and other coordinating support staff at Mount Sinai. The Imaging
Core will consist of an expert panel to incorporate expertise across all program project areas. The panel will
review imaging and data analysis protocols at inception and periodically during the projects to optimize and
update protocols employed in the program. Leveraging the existing experience, expertise, and infrastructures
of the current ongoing Program Project and Clinical Trials Unit (CTU) at BMEII, a group dedicated to operating
imaging-based clinical-trial-like research studies for intra-mural, extra-mural, and industrial collaborators, the
core members will assist with the technical imaging protocol development and implementation as well as
supervise image analysis for all Projects. In addition, the core will also serve as the image and data repository
for imaging data obtained from this Program Project Grant (PPG). The Imaging Core will also fulfill the role of
an “academic research organization” (an activity we have a substantial amount of experience in) for the two-
center human clinical trial proposed in Project 4 and be responsible for the validation of all systems used for
imaging and analysis, tracking data flow including maintaining an audit trail, operational management of the
trial and ensuring compliance with all federal and regulatory guidelines. Finally, the Imaging Core will be
responsible for centralized management of all the imaging data acquired as part of this PPG.